Neural Mechanisms of Response Inhibition Training for Obsessive-Compulsive Disorder and Related Conditions

PROJECT SUMMARY
The impaired ability to suppress an inappropriate but pre-potent response (response inhibition; RI)
characterizes several debilitating clinical problems, including obsessive-compulsive and related disorders
(OCRD) such as obsessive-compulsive disorder, trichotillomania, and skin picking disorder. There is a critical
need to develop an effective and durable treatment for OCRDs with demonstrable evidence for impacting
impaired RI, a transdiagnostic intervention target specified in the Research Domain Criteria (RDoC) Cognitive
Control systems. The objective of our R61/R33 application is to 1) examine the impact of a novel computerized
intervention, response inhibition training (RIT), on neural indices of RI, and 2) examine the mechanistic link
between engagement of the neural RI targets and change in symptoms in a randomized clinical trial for
individuals with OCD, trichotillomania, and/or skin picking disorders. The R61 phase aims to examine whether
RIT can attain the predetermined criterion-level change in neural RI indices (i.e., activation in right inferior
frontal cortex; rIFC) (Aim1). Adults with OCRD (N=48) will be randomized to RIT or placebo training (PLT), with
neural indices of RI assessed at pre- and post-intervention. If the rIFC is successfully engaged as a valid target,
the RIT should show a greater level of rIFC activation during a RI task at both between-groups and within-
group levels. The R61 “go/no-go” decision will be made by two effect size-based criteria: 1) η2=.06 or greater in
a between-groups comparison; and 2) d=.5 or greater in a within-group pre-post RIT comparison. The R33
phase aims to determine the effectiveness of RIT in improving OCRD symptoms (Aim2a), and to examine
whether the reduction in OCRD symptoms is mediated by changes in neural RI indices (Aim2b). To this end,
Adults with OCRD (N=70) will be randomized to RIT or PLT, with pre-to-post neural measures of RI and pre-to-
follow-up measures of OCRD symptoms. In both phases the RIT dosage (number of sessions) will be
individually quantified and adjusted based on the ongoing monitoring of the behavioral RI process. Resulting
data are expected to guide the development of RIT as a personally-optimizable intervention with a
demonstrated neurobehavioral mechanism of action for treating OCRD. This contribution is significant as it can
result in a transdiagnostically-applicable intervention capable of therapeutically modifying RI deficits. Our
approach is innovative because it proposes a fundamentally different therapeutic approach to OCRD using a
computerized, engaging (gamified), accessible, and cost-efficient intervention that can be easily implemented
and disseminated. Further, in our personalized-medicine approach, we will examine the feasibility of an
individually-optimizable intervention with a precise dose-control capability by monitoring the status of
behavioral RI target. These innovative features highlight the substantial public health impact afforded by our
effort to translate the accumulated neurobehavioral literature for RI processes to a widely applicable
intervention for RI-implicated problems.

Public health relevance
PROJECT NARRATIVE This study aims to examine whether the proposed computerized cognitive training program can improve the neural indicators of the ability to inhibit inappropriate responses, and produce a clinically meaningful level of reduction in obsessive-compulsive disorder and related symptoms. This project is expected to generate valuable knowledge to guide the development of an effective, personally-optimizable, theoretically-sound, and portable computerized intervention that can be applied to numerous clinical problems characterized by the poor ability to inhibit inappropriate responses, yielding significant public health impact.